Vision, Attention and Eye Movements at the Scale of the Foveola

PROJECT SUMMARY
Humans rely on the foveola, the region of the retina where cones are most densely packed, for exploring
the visual scene at high resolution. Although the foveola only covers a tiny portion of the visual ﬁeld—
approximately the size of a full moon—, damage to this area has devastating consequences for most daily
visual activities. Yet, primarily as a consequence of technical challenges, little is known about the mechanisms
of foveal vision and the sensorimotor strategies by which humans achieve high visual acuity.
A major difﬁculty in studying foveal functions comes from the need to ﬁnely control retinal stimulation. At
this scale, both placing and maintaining a stimulus at a desired eccentricity is difﬁcult, because of uncertainty
in localizing the center of gaze (typically as large as the foveola itself), and because of the continual retinal
motion caused by ﬁxational eye movements, the slow eye drifts and small saccades that humans continually
perform. The PI and her coworkers have recently circumvented these limitations and developed new methods
for mapping visual functions at the very center of gaze. Their research has shown that pattern vision varies
sharply across the foveola, and that both attention and eye movements are precisely controlled at this scale.
These previous ﬁndings raise a fundamental hypothesis: high acuity vision does not follow automatically
from placing the stimulus on the foveola, but it is the outcome of an orchestrated synergy of visual, motor,
and attentional components, which closely cooperate to sequentially extract ﬁne spatial information from the
foveal region. This project is designed to investigate this hypothesis, in three strongly inter-connected aims,
we will examine the role of attention in high acuity vision (Aim 1), how it is modulated by microsaccades (Aim
3), and how both attention and microsaccades deal with limits in visual processing of ﬁne patterns (Aim 2).
Speciﬁcally, in Aim 1, we will build upon our previous work on the ﬁne control of voluntary attention within the
foveola and study the spatial resolution of this phenomenon, its temporal dynamics, and whether it extends
to involuntary attention. In Aim 2, we will map visual acuity across the foveal space and examine how visual
acuity and crowding vary within the foveola. In Aim 3, we will investigate the accuracy and precision of mi-
crosaccades, their contributions to alleviating physiological limitations in acuity and crowding, and their links
to attentional control within the foveola. The interplay of vision, attention, and oculomotor activity will be stud-
ied not just in general terms (average results across observers) but also at the individual level, to determine
whether the degree of attentional and motor control covary and whether the latter is linked to idiosyncratic
differences in acuity. Our main hypothesis that ﬁne spatial vision is the outcome of a sensorimotor interaction
bears several important consequences. It raises the possibility that sub-optimal control of attention and ﬁxa-
tional eye movements may contribute to high acuity impairments. This research may open the way for visual
rehabilitation procedures that act on the ﬁne control of eye movements and attention.

Public health relevance
PROJECT NARRATIVE Humans critically rely on a tiny region of the retina, the foveola, to inspect objects of interest. By examining how foveal processing interacts with high-resolution control of attention and microscopic eye movements, this research will advance understanding of the mechanisms underlying ﬁne spatial vision in humans and may lay the basis for new treatment approaches for impairments in foveal functions.